Technology-Based Intervention For Reducing Sexually Transmitted Infections and Substance Use During Pregnancy

Project Summary
Sexually transmitted infections (STIs) are at a record high in the United States, and STI risk is an increasingly
critical and costly health problem for American childbearing women. STIs and alcohol/drug use are interrelated
and common morbidities that have direct and indirect relationships to health and functioning over the longer
term for mother and fetus. Because of the intersection between substance use and STIs, and because both
are associated with poor health outcomes, there is an urgent need to intervene with pregnant women in order
to jointly address risky sexual behaviors and substance use during this vulnerable time period. While
pregnancy has been recognized as a window of opportunity in which to intervene, very few interventions exist
that target both of these risks, and virtually none are tailored to pregnant women's specific context and unique
concerns. The objective of this R01 study is to fill this critical gap by building upon our promising R21 findings
to test whether the innovative, theory-driven “Health Check-up for Expectant Moms” (HCEM) reduces STI,
alcohol use and drug use risk more than a time and information matched control condition in pregnant women
seeking prenatal care. This research addresses priorities in line with NICHD's mission and Scientific Vision to
advance the health of women: (1) promoting research to develop interventions that influence a range of
behaviors and outcomes, (2) developing and enhancing personalized treatment that targets pregnant women,
and (3) decreasing the potential for poor birth outcomes among women at greatest risk. We propose a two-
group, randomized controlled trial in which a racially diverse sample of 250 high-risk (at risk for STIs and
alcohol/drug use) pregnant women attending prenatal care in high-volume primary care clinics will be assigned
to either (a) a computer-delivered, single-session brief intervention plus two booster sessions (within one
month after the intervention) consistent with motivational interviewing and informed by the Information-
Motivation-Behavior (IMB) model, the HCEM, or (b) a computer-delivered control condition. Computer-
delivered follow-up assessments will occur at 8 and 24-weeks antenatally, and at 6-weeks postpartum,
extending outcomes to the postpartum period. Specific Aim 1 is to test the hypothesis that HCEM, compared to
an attention, time and information matched control condition, will reduce unprotected sexual occasions, alcohol
use and drug use among at-risk pregnant women during pregnancy at 2 and 6-months follow up. Specific Aim
2 is to test the hypothesis that HCEM, compared to control, will reduce STIs and alcohol/drug use at 6-weeks
postpartum and will result in better birth outcomes. An economic evaluation of the costs of the intervention will
occur to guide future implementation and dissemination. Specific Aim 3 is to explore direct and indirect effects
in the above hypotheses. Results of this program of research are expected to inform the development of
integrated STI and alcohol/drug use interventions that are cost-effective, high-reaching and widely
disseminable during pregnancy with benefits for mother and infant extending impact to the postpartum period.

Public health relevance
Public Health Relevance Sexually transmitted infection (STI) risk, alcohol, and drug use are increasingly common, interrelated factors that are associated with numerous negative consequences for the woman and the developing fetus. There are virtually no empirically supported interventions that address these public health concerns together during pregnancy. This study will test an innovative computer-delivered brief intervention to fill this critical healthcare gap; if this promising intervention is found efficacious, it can be readily integrated into prenatal health care settings and thus reduce the risk for adverse outcomes for very large numbers of vulnerable women and infants.